RESIDUAL CONCENTRATIONS OF SERUM ESTROGENS ON BONE TURNOVER IN POSTMENOPAUSE

The purpose of this study is to test if low levels of estrogens in the blood stream have an effect on bone density many years after menopause.